MEASUREMENTS AND METABOLISM OF NEUROSTEROIDS IN THE CENT

The principal objective of this study is to determine the effect of ethanol on the metabolism of neurosteroids in the central nervous system (CNS). Neurosteroids such as 5alpha-pregnane-3alpha-ol-20-one (THP or Allopregnanolone) and 5alpha-pregnane-3alpha,21-diol-20-one (THDOC) have been shown to modulate the GABA/benzodiazepine binding sites and to exert anxiolytic and hypnotic effects. Modulation of these neurosteroids in the CNS by ethanol may be one of the underlying mechanisms for stress- related situations in humans, a side effect often observed in alcoholics during withdrawal. As part of a continuing effort to establish a mass spectrometric technique which has adequate sensitivity to routinely measure trace levels of neurosteroids in cerebral spinal fluid (CSF), we explored other approaches using gas chromatography mass spectrometry (GC/MS) after derivatizing neurosteroids with an electron capturing moiety. In this mode, with the exceptions of progesterone and dihydroprogesterone, various neurosteroids were detected at 1 pg level. Characterization of the level of neuroactive steroids in rat brain and plasma as well as in monkey CSF is now in progress using this method.